Host Factors Controlling Neuroinvasive Flavivirus Pathogenesis

ABSTRACT
Flaviviruses such as Powassan virus (POWV), West Nile virus (WNV), and Japanese encephalitis virus (JEV)
are transmitted by ticks and mosquitoes. The outcomes of flavivirus infection are heterogeneous, with only a
subset progressing to neuroinvasive disease (e.g. encephalitis, meningitis, or paralysis). We hypothesize that
host genetic variation, particularly in antiviral response genes, contributes to differential disease outcome
following flavivirus infection. The Collaborative Cross (CC) panel of recombinant inbred mice provides an ideal
system to discover novel mechanisms of immune-mediated control of flavivirus pathogenesis because these
mice exhibit an expanded range of immune phenotypes on reproducible genetic backgrounds. We infected 17
CC lines with POWV and identified multiple highly susceptible lines, including CC071 and CC015, and a single
resistant line, CC045. Most phenotypes were concordant among POWV, WNV, and JEV, but some lines
exhibited virus-specific resistance, implying that there are both virus-specific and pan-flavivirus mechanisms that
control resistance to neuroinvasive flaviviruses. We propose to use the CC to determine the viral and
immunologic features of POWV pathogenesis and to identify host genes that contribute to POWV resistance.
Aim 1: Define viral and immunologic features of POWV pathogenesis in CC mice. We found that CC045
mice exhibited equivalent viremia but lower brain viral loads compared to CC071 mice, suggesting that POWV
resistance may result from reduced neuroinvasion. We will assess brain viral loads and infiltrating leukocytes in
susceptible and resistant CC lines following POWV infection. We will assess blood-brain barrier permeability at
baseline and in response to viral infection and inflammatory stimuli. We will generate primary cells from
susceptible and resistant CC lines and measure replication of POWV and other flaviviruses.
Aim 2: Map quantitative trait loci and evaluate antiviral activity of host factors associated with POWV
resistance. To identify polymorphic host genes that determine the outcome of POWV infection, we generated
two F2 crosses of susceptible and resistant lines (CC071 x CC045 and CC015 x CC045) and evaluated lethality
in ~300 F2 mice per cross following POWV infection, as well as CNS viral loads in ~120 F2 mice. We will map
QTL associated with POWV resistance in both crosses and investigate candidate genes under significant QTL.
Aim 3: Distinguish pan-flavivirus and virus-specific restriction factors in CC mice. We will infect
additional CC lines with JEV to identify lines that are differentially resistant to JEV compared to POWV or WNV.
We will evaluate brain viral loads and infiltrating leukocytes following JEV infection. We will generate F2 progeny
of susceptible and resistant lines and map QTL associated with JEV resistance.
The proposed studies will provide insight into the pathogenic mechanisms of POWV and reveal polymorphic
host immune mechanisms that impact susceptibility to flavivirus neuroinvasive disease. This work will provide
the foundation for future investigations of novel immune factors that control flavivirus pathogenesis.

Public health relevance
PROJECT NARRATIVE Powassan virus is a tick-borne flavivirus that is becoming more common in the United States and can cause neuroinvasive disease such as encephalitis, meningitis, or paralysis. However, disease severity varies dramatically among people and it is not well understood how host genetic differences contribute to the outcome of neuroinvasive flavivirus infection. We will use genetically diverse Collaborative Cross mice to understand how polymorphisms in host antiviral response genes influence the disease caused by Powassan virus and other neuroinvasive flaviviruses such as the mosquito-borne West Nile virus and Japanese encephalitis virus.